Role of Prokineticin 2 in Metal Neurotoxicity

Abstract
This administrative supplement proposal aims to uncover a novel compensatory neuroprotective mechanism
of prokineticin 2 (PK2) signaling within the context of environmentally linked Alzheimer's disease-related
dementia (ADRD). ADRD represents a significant subset of dementia conditions, primarily characterized by the
presence of Alzheimer's disease (AD) pathology in the brain, including a range of cognitive impairments, memory
deficits, and behavioral changes that affect daily life and functioning. AD, the most common form of dementia, is
characterized by the accumulation of amyloid-beta (Aβ) plaques, abnormal tau protein tangles, chronic
neuroinflammation, neuronal loss, and synaptic disruption. These pathological changes contribute to cognitive
decline, memory loss, and behavioral symptoms in AD patients. The olfactory system is closely connected to
brain regions involved in memory and cognition, and growing evidence indicates that olfactory dysfunction often
occurs in the early stages of AD, frequently even preceding cognitive symptoms. Exposure to the environmental
metal manganese (Mn) has also garnered attention in the context of AD/ADRD research. Chronic exposure to
high levels of Mn, often associated with occupational settings, has been linked to olfactory dysfunction, cognitive
impairment, and neurological symptoms reminiscent of AD. Despite the established link between olfactory
dysfunction and memory-cognitive impairments, the exact molecular mechanisms responsible for the
compromised olfaction and cognition in environmentally linked AD have not been fully elucidated. As outlined in
our parent R01 proposal, we recently reported rapid upregulation of the neuropeptide prokineticin 2 (PK2) during
early-stage Mn neurotoxicity, serving as a compensatory response to protect against neurodegeneration through
pro-survival pathways. Additionally, our preliminary findings demonstrate that stimulating PK2 signaling led to a
significant increase in glial-derived neurotrophic factor (GDNF) expression and release from astrocytes. Thus,
we hypothesize that cognitive deficits, impaired OB function, and Aβ/tau pathology in AD may result from reduced
PK2-GDNF-mediated compensatory signaling in the brain. Additionally, chronic Mn exposure may further deplete
brain PK2-GDNF signaling, thereby intensifying ADRD-related pathology. To test this hypothesis, we will pursue
the following specific aims: (i) Map the spatial and temporal expression of PK2-GDNF and their receptors across
the cortex, hippocampus, OB, and basal ganglia regions, and establish functional correlations with region-
specific neuronal susceptibility, the accumulation of Aβ/tau pathology, olfactory dysfunction, and cognitive
deficits in the HTAP mouse model of AD; and (ii) Examine whether chronic exposure to Mn amplifies the
depletion of hippocampal PK2-GDNF protective signaling, consequently exacerbating disease progression in
HTAP mice. Overall, we predict that our proposed studies will provide novel mechanistic insights into metal-
induced olfactory and cognitive dysfunction and its role in the pathogenesis of environmentally linked ADRD and
will offer a novel therapeutic strategy.

Public health relevance
Narrative Chronic exposure to elevated manganese (Mn) levels, typically found in occupational environments, has been associated with olfactory dysfunction, cognitive impairment, and neurological symptoms resembling those seen in AD/ADRD. Nevertheless, the precise molecular mechanisms underlying these compromised olfaction and cognition in environmentally related AD/ADRD remain unclear. This proposal aims to investigate the involvement of a compensatory signaling pathway, mediated by the neuropeptide prokineticin 2 (PK2), in the context of an environmentally linked AD model.